Clinical Core

PROJECT SUMMARY/ABSTRACT: Clinical Core
The mission of the HU CFAR is to expand, promote, and facilitate collaborative innovative multidisciplinary
HIV/AIDS research among its members to bring an end to the HIV epidemic. Critical to this mission is the
Clinical Core, which provides essential resources to support and foster clinical and translational research
among clinical, social, behavioral, and basic scientists. The primary goals of the Clinical Core are to facilitate
access for investigators and prospective study participants to clinical research, to provide regulatory support to
CFAR investigators’ human studies research, to facilitate storage and access of specimens and research data
from people living with and without HIV, and to catalyze clinical and translational research at HU CFAR and
through inter-CFAR collaborations. These efforts include close linkages to and communication with
communities affected by HIV and engagement of research participants in underserved populations. Critically,
the services supported by the CFAR Clinical Core are either not funded or are inadequately funded by other
support mechanisms and, thus, the value added by this Core has been immense. In the past 5 years, the
Clinical Core has supported 47 NIH-funded investigators and 160 active NIH projects; importantly, 28% of the
investigators were Early Career Investigators. During this time, there have been 105 users of the Clinical Core
with over 306 documented instances of core services. Clinical Core resources were cited in 125 publications,
including in high-impact journals such as Nature, Nature Medicine, Science, Cell, Immunity, and the New
England Journal of Medicine. The impact of the Clinical Core extends well beyond Boston and Cambridge, by
providing a link to multiple international collaborating sites, both in terms of facilitating access to clinical
samples and through a series of innovative educational programs designed to enhance clinical research.
While the mission of the Clinical Core remains to facilitate clinical and translational research, the Core
continues to evolve and modify its programs to meet the emerging needs of investigators. To meet the ongoing
needs of CFAR investigators, promote scientific discovery and support the next generation of HIV researchers,
we will accomplish the following specific aims:1) Expand essential infrastructure support for CFAR
investigators conducting clinical and basic science research related to HIV infection, HIV-associated
comorbidities and coinfections, HIV prevention, and Ending the HIV Epidemic efforts. 2) Develop and provide
access to online resources for CFAR investigators and prospective study participants. 3) Support novel
educational and outreach programs designed to facilitate clinical and translational research at HU CFAR and
through inter-CFAR collaborations. 4) Provide mentorship and research guidance for Early Career
Investigators and those under-represented in medicine.